Center for Biomedical OCT Research and Translation

Project Summary: Artiﬁcial intelligence in general and machine learning speciﬁcally, represent tremendous potential for medical imaging. Multiple projects within our Center for Biomedical OCT Research and Translation include the development and training of machine learning algorithms for interpreting, quantifying, and improving OCT. Through P41 support, we have previously established a collaboration with MIT Computer Science Professor Polina Golland and presently co-mentor a post-doctoral fellow with her. We have recently conducted interviews with candidates to ﬁll this fellowship and will use supplemental funding to bring in a new fellow so that we maintain progress in this important technical area, which underpins multiple TRD projects. In addition, we will expand on our dissemination eﬀorts through enhancements to our website and through new social media channels. Finally, we will maintain important recent progress that has been made in the development of high repetition rate wavelength swept lasers. Through an external vendor, we have developed high performance, chirped period ﬁber Bragg gratings. It is important to maintain the momentum of this project as the laser developments will enable multiple diﬀerent TRD projects. Relevance: The Center for Biomedical OCT Research and Translation has been highly productive in the development of novel imaging technologies, instruments, and applications. Several of our projects have led to commercial medical devices that improve health care. We have also been very successful in service projects that have made sophisticated imaging instruments available to a wide spectrum of collaborators in our Center and also in remote research settings. Maintaining these core eﬀorts through an interim year will permit our programs to continue without deceleration in our next competitive grant cycle.

Public health relevance
Narrative: Optical coherence tomography meets unique imaging needs in biological and clinical research, with unprecedented abilities for high resolution, minimally invasive imaging. The proposed research and training activities will advance OCT capabilities and further their availability to a nationally-diverse, broad range of biological and medical collaborators.